Proteasomal recruiters of PAX3-FOXO1 Designed via Sequence-Based Generative Models

Abstract
Fusion-positive alveolar rhabdomyosarcoma (FP-ARMS), one of the most fatal childhood cancers, is primarily
dependent on the PAX3-FOXO1 fusion oncoprotein, a chimeric transcription factor that hijacks normal gene
expression and chromatin state. The five-year survival for children with PAX3-FOXO1-positive ARMS is ~30%
and <10% when metastatic. PAX3-FOXO1 is largely considered an undruggable protein, with no small molecule
developed to bind and inhibit its activity. Recently, we have developed novel algorithms to design specific
peptides that selectively bind and degrade pathogenic proteins, including classically “undruggable” transcription
factors and fusion oncoproteins. In this proposal, we will ensemble our state-of-the-art generative models to de
novo design high-affinity peptide-guided degraders selective to PAX3-FOXO1 (and not PAX3 or FOXO1) and
demonstrate degradation within in vitro models of FP-ARMS. The outcomes of this work will motivate
downstream in vivo studies and accelerate protein-targeting medicines for FP-ARMS.

Public health relevance
Public Health Relevance Cancer is the leading cause of death by disease in children in the United States. While outcomes for some low and intermediate risk-groups have improved significantly over the last several decades, survival for high-risk groups has remained stagnantly poor. The goal of this project is to develop a novel protein degrader system targeting the main oncogenic driver of one such high-risk cancer, called fusion-positive rhabdomyosarcoma, in order to develop more effective and less toxic therapies.